Interdisciplinary Population Health Science Training: Linking Multilevel Forces Across Time

PROJECT SUMMARY/ABSTRACT
The Minnesota Population Center (MPC) at the University of Minnesota (U of MN) requests five more years of
support for its interdisciplinary training program in Population Health Science. Rationale: Effectively addressing
complex public health problems requires training a new generation of scientists who view biological, social,
economic, spatial, and policy factors as interacting over multiple time scales to shape population health.
Unfortunately, training programs usually prioritize etiologic research over investigations of effective solutions,
and most new scientists are trained only in the biological, social, or health care system influences on disease;
few are trained to integrate all three. Objectives: We seek continued support for a pre- and postdoc training
program in population health science that produces scientists who understand complex health problems and
health disparities as resulting from multiple and interacting layers of influence that unfold over chronological,
biological, and historical time. Design: The program features cross-training in (a) the biology and etiology of
disease and (b) social sciences and policy contexts that shape disease. The program includes required
coursework (for predocs only) in population health science, population modeling, and the responsible conduct of
research; independent and collaborative research supervised by interdisciplinary teams of faculty mentors;
required Scholar Development Meetings, workshops, and participation in interdisciplinary population health
conferences; and intensive professional socialization designed to integrate trainees from diverse disciplinary
backgrounds and prepare them to have outstanding careers as population health scientists. Trainee Outcomes:
We train population health scientists to integrate knowledge, theory, and tools from multiple disciplines to conduct
cutting edge research on the intersecting biological and social factors that shape health and to produce novel
solutions to the nation’s most pressing public health issues. Appointments: We request five predoc (3-year) and
three postdoc (2-year) training slots; this represents an increase in training slots from the previous project period
(from four predoc and two postdoc slots). Our request for more training slots is based on the extraordinary
success of our program in the first project period. Leadership: The program is co-directed by population health
scholars John Robert Warren (Sociology) and Theresa Osypuk (Epidemiology & Community Health). They are
supported by an internal Executive Committee, an external Advisory Board of nationally recognized population
health scientists, and an outstanding team of 49 faculty mentors from five colleges and twelve disciplinary
departments. Progress: In the first five years of the program, we successfully placed all alumni trainees in
population health research positions; our trainees were extremely successful in publishing, competing for
research funds; and developing identities as interdisciplinary population health researchers.

Public health relevance
NARRATIVE Major modern health problems can rarely be solved through clinical interventions or medical advances alone. Social, economic, and policy contexts also shape population health in profound ways, requiring an integrative approach to studying multiple layers of influence on population health over multiple time scales: a “cells-to- society” approach. We propose to renew this pre- and postdoctoral training program that rigorously integrates knowledge, theories, and methods from disciplines across public health, public policy, medicine, and the social sciences to train the next generation of population health scientists to tackle and solve seemingly intractable public health problems.